LITERATURE SUMMARIES, ASSESSMENTS, FOR BEST PHARMACEUTICALS FOR CHILDREN ACT

The NICHD, as delegated by the NIH, is responsible for implementing the Congressionally-mandated Best Pharmaceuticals for Children Act of 2002, as reauthorized in 2007. The NICHD is responsible for the performance of clinical trials of priority, [unreadable]off patent[unreadable] drugs that are used in children but that lack sufficient pediatric labeling. NICHD responsibility includes administrative activities as well as support, and coordinating support and participation of other ICs in BPCA activities. The function of this project is to provide literature summaries, assessments, and meta-analysis for the BPCA. Data used to conduct pharmacology studies in children.